Molecular regulation of lymphoid lineage priming in steady state and regeneration

Project Summary/Abstract:
Continuous functional T and B lymphoid output is critical to overall health and life, as delayed and reduced
lymphopoietic output has been associated with serious illness and even mortality. The lymphoid system is
particularly sensitive to hematopoietic perturbation, both in the context of steady state and regeneration.
Hematopoietic stem cell transplantation (HSCT) into irradiated recipients and stress from infection or other insults
in native hematopoietic systems have been shown to negatively regulate lymphoid output. One of the challenges
to developing clinical therapies to restore healthy immune function is that we don’t have enough information on
lymphoid development in vivo. This is true for both the embryonic immune system which hPSC blood
differentiation systems attempt to reproduce and the adult immune system. Understanding the mechanisms by
which lymphoid output from HSPCs is controlled at clonal, transcriptional, and epigenetic levels is critical for
revealing how lymphoid output is established and regulated in steady state, how it is suppressed with
regeneration, and whether there is a specific signature associated with reduced lymphoid output that is
conserved between native and non-native systems. It was recently shown that the HSC specific transcription
factor Tcf15 is indispensable for long term self-renewal, following HSCT. Intriguingly, I have demonstrated that
Tcf15 also negatively regulates both T and B lymphoid differentiation. This was true both in native hematopoiesis
and regeneration. It is well established that HSCs display multilineage priming. This allows HSCs to readily
regenerate the hematopoietic system, upon perturbation and to differentiate into lineage restricted progenitor
cells to meet native hematopoietic demands. In addition, reduced lymphoid lineage priming has been shown to
promote HSC expansion. For the mentored K99 phase of this proposal, I will transition from a focus on Tcf15 in
native hematopoiesis, to a focus on Tcf15 in lymphopoiesis, a focus that will allow me to establish research
independence from my mentor. With the evidence of multilineage HSC priming, the evidence of native
antagonism between HSC self-renewal and lymphoid differentiation programs, and my preliminary data
hypothesize that Tcf15 expression attenuates lymphoid lineage priming in HSCs and that this is conserved
between steady state and regeneration. I propose to test this hypothesis in two aims: In Aim 1, I will apply scRNA-
seq, scATAC-seq, and proteomic analyses to elucidate the transcriptional and epigenetic program by which
Tcf15 regulates T and B lymphoid differentiation from HSPCs. In Aim 2, I will use Tcf15 reporter and CRISPR-
based lineage tracing (CARLIN) mouse models generated in our lab to explore the effect of endogenous Tcf15
on T and B cell specification from HSCs. For the R00 component of this award, I will seek to continue my
examination of regulation of lymphoid lineage priming, but downstream of HSCs, exploring whether I can apply
lineage and transcriptional tracing methods to retroactively connect T and B cell differentiation outcomes to
distinct lympho-myeloid primed progenitors (LMPP) identities in health and age, in an unbiased manner.

Public health relevance
Project Narrative: Understanding the intrinsic factors that regulate T and B lymphoid development from HSPCs is key to understanding hematopoietic system function in health, stress, and pathology. Self-renewal and lymphoid priming mechanisms in HSCs have been shown to be mutually antagonistic. My studies aim to understand the transcriptional, clonal and epigenetic landscape that regulate lymphoid development from HSPCs in native hematopoiesis and perturbation.